Optimizing a Stapled-Peptide That Specifically Targets HSV-1 to Treat Herpes Ocular Keratitis

ABSTRACT
Infection of the eye by Herpes Simplex Virus-1 (HSV-1) can result in Herpes Keratitis (HK), which is the
leading cause of infectious corneal blindness worldwide. In the U.S., nearly 500,000 individuals
experience ocular herpes infections that are often recurrent and culminate in progressive corneal scarring
and loss of vision. The gold standard treatment is Acyclovir (ACV) that targets HSV-1 thymidine kinase
(TK). However, emergence of ACV viral resistant mutants in 7-14% of ocular HK patients has created the
urgent need to discover a second drug directed against a different HSV-1 target. A new class of antiviral
targets are processivity factors (PFs) that are essential for tethering their cognate polymerases (Pols) to
the template to enable continuous DNA synthesis. During HSV-1 replication, the DNA-anchored PF binds
to the extreme C-terminus of Pol (C-Pol) to keep Pol from dissociating from the viral template. When
co-crystallized with its PF, the C-terminus of the viral Pol (C-Pol) forms an α-helix, with one face making
multiple bonds with several residues of PF while the other face is solvent exposed. Our goal is to develop
a novel antiviral drug that specifically targets herpes PF for the purpose of treating ACV resistant HK.
Stapled a-helical peptides have emerged for use in targeting protein-protein interactions that often
display as long flat surfaces which are difficult for small molecules to bind efficiently. Peptide a-helices
are ideal structural motifs for incorporating chemical staples to provide rigidity to make natural bonds
with residues on the target protein. Moreover, staples can create a protease shield to prolong residence
time. We have now engineered a stapled peptide of C-Pol (SPep7B) that blocks the mechanism of
processive DNA synthesis in vitro and HSV-1 infection in human organotypic (3D) corneal epithelial cells;
the unstapled peptide is non-inhibitory. SPep7B was shown to eliminate HSV-1 viral DNA in infected
cells while failing to block a different virus. Importantly, SPep7B exhibits undetectable toxicity
(CC50>100µM) by two different assays in human ocular epithelial cells. Our GOAL is to enter SPep7B
into preclinical development as a Topical to treat HK. This will be accomplished by conducting a
series of AIMS that include scaleup of SPep7B and evaluating two formulations for delivery of SPep7B into
human 3D cultures and then ex-vivo excised rabbit cornea for permeability and toxicity. These studies are
essential to confront the physiological and anatomical barriers to topical ocular delivery. In vivo studies
will evaluate SPep7B for tolerability, genotoxicity, PK, and repeat dosing. An efficacy study will evaluate
SPep7B for clinical cure and viral clearing. Backup analogs of SPep7B will be prepared and evaluated
for risk mitigation. A model for new antiviral drugs: Closely aligned with this approach is the
potential for using PFs and stapled peptides of other viruses for treating unmet medical needs caused
by infections that lead to deleterious complications.

Public health relevance
NARRATIVE Herpes Keratitis is the leading cause of corneal blindness in the USA and the world. The significant emergence of acyclovir-resistant herpes virus in eye infections necessitates the development of a new, safe and effective drug. The goal of this research is to prevent loss of vision by continuing the development of a novel, n0n-toxic drug that specifically targets herpes virus that infects the eye.